Breast Cancer Intravoxel-incoherent-motion MRI Multisite (BRIMM) Study - Resubmission - 1

PROJECT SUMMARY
While the technological enterprise of magnetic resonance imaging (MRI) generates a host of biomarkers of the
tumor environment, in particular for breast cancer, precious few (and typically only first-order markers) have
been tested beyond single site studies with single workflow processing. To address both the need for advanced
tissue characterization and multi-site translation, we propose a multi-site study of intravoxel incoherent motion
(IVIM) MRI in breast cancer to determine its maximum translational prognostic benefit. The IVIM model, which
includes separate markers of tissue cellularity, vascular volume, and micro-vascular flow, has been successfully
applied in a range of cancers, including breast cancer by the project teams of this proposal. This project will
determine inherent variability of the technique with hardware variation (3 vendors) and software platforms (6
packages), in a 5 site retrospective analysis of clinical breast cancer IVIM data. We will then conduct a
prospective two-site IVIM longitudinal study of patients undergoing neoadjuvant chemotherapy to determine the
best pre- or mid-treatment biomarkers to predict therapeutic response. At each stage, performance will be
evaluated both within each site and in the combined cohort, with the goal of identifying biomarkers that are both
useful and broadly translatable.

Public health relevance
PROJECT NARRATIVE Imaging biomarkers must be complex enough to represent the relevant features of aggressive breast cancers, but straightforward enough to be applicable at many sites for broad adoption. This project will target the balance of these two needs with a study of advanced imaging (intravoxel incoherent motion (IVIM)) at multiple sites in a cohort of breast cancer patients. The outcome of the study is expected to identify noninvasive imaging biomarkers that not only relate to tumor biology but can be broadly applied for prediction of response to pre- surgical (neoadjuvant) therapy, one of the crucial ingredients of breast cancer survival.